PROTEIN TRANSLATION INITIATION FACTOR 4D--STRUCTURE, BIOSYNTHESIS AND CONTROL

Eukaryotic protein translation initiation factor 4D (eIF-4D) contains one residue of hypusine and appears to be the only cellular protein with this one unique amino acid. Hypusine is produced posttranslationally by transfer of the butylamine portion of the polyamine spermidine to a lysine residue in the eIF-4D precursor and subsequent hydroxylation. These findings reveal a novel cellular metabolic pathway. Studies are underway to relate the structure of hypusine to the function of eIF-4D and to understand the posttranslational control of hypusine biosynthesis.